Defining the structure-interactome relationships of the basigin glycoprotein in endometriosis

Endometriosis is characterized by the extraneous presence of endometrial cells outside the uterine organ. The
molecular mechanisms governing the migration of endometrial cells and the corresponding regulators of
endometriosis are yet to be known, leaving critical gaps in the search for targets that can be used to treat
endometriosis. We have recently found that an N-linked glycoprotein called basigin contributes to
endometriosis. Here, we will apply proximity labeling technologies to define the interactome of basigin in cell
culture models of endometriosis. Given the density of glycan post-translational modifications on basigin, we
also reason that N-linked glycosylation can contribute to its interactome. The resulting interactomes will be
used to define how basigin is regulating endometriosis and also open new potential targets for intervention.

Public health relevance
Significant gaps remain in our understanding of the molecular etiology of endometriosis. We propose to investigate the role of an N-linked glycoprotein called basigin in regulating the behavior of endometrial cells. Our studies will establish basigin as a potential target for the therapeutic targeting of basigin to alleviate endometriosis.